Data-Analysis-Core

ABSTRACT
Data Analysis Core. The Data Analysis Core (DA) will construct biomarker and map datasets generated from
whole human lung and heart tissue, cells, and tissue-based 3D models. The DAC will deliver robust and
standardized data to the TriState SenNet TMC and the SenNet Data Coordinating Center (CODCC). The overall
goals of the DAC are to store, analyze, and model the biomarker and map datasets generated from the tissues
provided by the Biospecimen Core (BC) and analyzed by the Biological Analysis Core (BAC) using robust
computational packages and analysis methods, align with data from the BC, and work together with other TMCs
and the CODCC to develop network-wide open data and metadata standards, and to conduct cross-validation
of assays within and across TMCs. We will achieve these goals by: 1) providing biostatistics and informatics
support to ensure the integrity of data collection, storage, transfer, and harmonization within the TriState SenNet
TMC; 2) constructing a lung and heart senescence atlas using advanced and robust statistical, computational,
and artificial intelligence algorithms; and 3) collaborating closely with the CODCC and other TMCs on developing
open data and metadata standards and cross-validating assays within and across TMCs.